Environmental Regulation of Cellular Responses to DNA Damage

SUMMARY
The overarching goal of this project is to understand how the DNA Damage Response (DDR) activates
apoptotic cell death. The DDR is a kinase driven signaling pathway that coordinates multiple cellular functions,
including: surveillance for DNA damage, recruitment of DNA repair enzymes, and activation of cell cycle
checkpoint arrest. Collectively, these events promote survival following genotoxic stress. Alternatively, in some
cases the DDR activates apoptosis. Although much is known about these each of these functions, it still
remains unclear why activation of the DDR leads to survival in some cases and death in others. The current
model suggests that p53 controls the decision to arrest and repair, or alternatively, to activate cell death. This
model does not explain the common observation that cancer cells – which often lack p53 – can robustly
activate apoptosis when exposed to DNA damage. Thus, other unidentified mechanisms must also exist to
facilitate DDR-induced cell death. Our strategy for identifying mechanisms by which the DDR activates
apoptosis was to perform functional genetic screens in cells that lack p53 but retain high levels of DNA
damage sensitivity. Our screen has identified that activation of caspase-1 and caspase-1 associated
inflammatory cytokine signaling is required for robust DNA damage induced cell death. This was unexpected
because unlike other members of the caspase family, caspase-1 is not thought to contribute to apoptotic cell
death. In this proposal, we will use live cell microscopy experiments to determine the fate of cells that have
activated caspase-1. Additionally, we will use biochemical and genetic experiments to determine mechanisms
by which caspase-1 is activated by DNA damage. Finally, we will use high-throughput targeted proteomic and
genomic analyses, together with data driven statistical modeling, to determine mechanisms by which caspase-
1 signaling is integrated with the DDR to promote apoptotic cell death. A major outcome from this study will be
an understanding of how intra-cellular and inter-cellular crosstalk between inflammatory and DDR signaling
helps to facilitate activation of apoptosis. This information may help to understand the variable sensitivity to
DNA damage that is observed across tissues and across people, and may ultimately improve our ability to
reliably control life-death decisions following DNA damage.

Public health relevance
Public Health Relevance Errors in how cells sense and respond to DNA damage can lead to serious diseases, including pre-mature aging, neuro-degeneration, and cancer. In spite of the importance of this process – and in spite of the fact that DNA damaging drugs are used in the treatment of most cancers – we still have a poor understanding of how DNA damage activates programmed cell death. This proposal will resolve mechanisms by which DNA damage activates programmed cell death, which will improve the effectiveness and the specificity of DNA damaging therapies in a variety of contexts.